Integration of Systems and Synthetic Biology to Advance Development of Human Tissues In Vitro

Project summary/ abstract:
Organoids reproduce the complex differentiation, cell sorting and self-organization of organogenesis, enabling
the study of tissue development and modeling of organ physiology and disease ex vivo. The induced human
Pluripotent stem cell (ihPSC) derived organoids are on their way to revolutionizing the future of human
cell/organ transplantations. However, a major challenge is centered around the limited ability to control and
direct the dynamic process of self-organization at the cellular population level. This drawback diminishes our
engineering efforts to build reliable human tissues by mimicking natural biological processes. As such,
currently, human organoids exhibit (a) aberrant cell types and (b) stalled developmental stages (immaturity) (c)
limited robustness and reproducibility during multilineage tissue formation. In this proposal, we will harness the
power of synthetic and system biology and provide a framework to build next-generation organoids with
augmented performance and robustness for regenerative medicine. Our method is guided by computational
models and genetic technologies. We have recently discovered that in our liver organoids, GATA6-engineered
circuits can dictate final cell fates based on the initial GATA6 expression level. Here in Aim 1, we will establish
a clonally resolved engineering approach to build human organoids. We will use our library of genetically
engineered clones to rationally design mixtures of clones that exhibit specific quantitatively defined outcomes
at the tissue level and use this to augment and reconstitute mesodermal niche important for liver maturation.
The successful completion of this aim enables us to build human organoids with a high degree of
reproducibility. In Aim 2, we devise a computational platform to design and build organoid variants with defined
hepatic functions. The successful completion of this study will result in a hypothesis-driven framework for
rational engineering and advancement of stem cell-derived tissues ex vivo. Our study will also generate liver
tissues with close proximity to adult human liver and reduces dependence on animal experiments and
increases access to refined human tissues.

Public health relevance
In vitro stem cell derived human organoids face challenges to faithfully recapitulate human biology due to limited efficiency and robustness during engineering as well as immaturity of their developmental status. In this proposal, we will use genetically programmed organoids to study cellular decisions and devise strategies to engineer tissue cell composition and function. Our approach will generate a new paradigm for engineering stem cell derived multicellular system.